Immunogenetic Profiling for Risk of Primary Graft Dysfunction after Heart Transplantation

Immunogenetic Profiling for Risk of Primary Graft Dysfunction after Heart Transplantation
For the approximately 250,000 people in the United States living with end-stage heart failure, heart
transplantation (HT) remains the gold standard therapy. Despite excellent long-term survival, early mortality
remains high as a result of infection, rejection, and primary graft dysfunction (PGD). PGD, in particular, is a
devastating complication of HT in which acute failure of the new allograft leads to hemodynamic instability and
end-organ hypoperfusion. Thus, we propose herein to build upon interesting preliminary data suggesting that
plasma levels of CLEC4C, a protein that serves as a cell surface receptor for plasmacytoid dendritic cells
(pDCs), are higher prior to transplant in patients who subsequently develop PGD after HT. Specifically, we will
integrate immune profiling, single cell sequencing of pDCs and PBMCs, and single cell proteomics in
isolated pDCs to test the hypothesis that pDCS are quantitatively and functionally enriched in HT
recipient who develop PGD. This study has the potential to identify clinically relevant biomarkers in the care
of HT recipients and may help to elucidate the underlying molecular mechanisms of PGD.

Public health relevance
After heart transplantation, primary graft dysfunction, or acute failure of the new organ, increases risk of early mortality and is expected to affect 10-30% of all heart transplant recipients. Preliminary data suggests that higher levels of a protein CLEC4C, a surface membrane protein of plasmacytoid dendritic cells, is higher in the pretransplant serum of heart transplant recipients who develop primary graft dysfunction. This project will use human blood samples from patients who are having a heart transplantation to better understand the role of these specialized immune cells in primary graft dysfunction. These results could mean better blood-based biomarkers to identify patients at risk of this disease.